Request for a ThermoFisher Helios 5UC DualBeam

7. Project Summary/Abstract:
This request is for funds to purchase a ThermoFisher Helios 5UC DualBeam Focused Ion Beam Scanning
Electron Microscope (FIB-SEM) system. This instrument is being requested by a group of NIMH-funded
investigators who have a significant need to acquire 3-dimensional (3D) volumes of brain tissue imaged at
nanometer resolution. The requested FIB-SEM system will be housed in a dedicated facility within the
Translational Neuroscience Program (TNP) at the University of Pittsburgh School of Medicine (UPSOM).
Installation of the requested Helios 5 UC DualBeam FIB-SEM represents an important expansion of existing
shared microscopy facilities that are specialized for, and dedicated to, brain tissue imaging.
There is a pressing and prevalent need for 3D large volume electron microscopy (VEM) approaches that permit
studies interrogating the basis of brain mechanisms underlying complex behaviors and their disruptions in
psychiatric disorders. The advent of 3D volume electron microscopy (VEM) addresses this critical need by
generating highly detailed connectomic maps of individually resolved synapses, and the sub-synaptic organelles
within, across densely packed, large volumes of brain tissue. The requested FIB-SEM system permits automated
and quantitative VEM imaging of brain tissue that avoids many of the limitations associated with other VEM
approaches. Although FIB-SEM application to neuroscience research is relatively recent, we show that this
technology can be applied to postmortem human brain tissue to create 3D, information-rich datasets of volumes
of brain tissue neuropil ready for quantitative analysis. Thus, with this technology we can interrogate the fine
structure of the nervous system and pinpoint structural disruptions contributing to brain dysfunction.
The need for this instrument is also demonstrated by the overwhelming response from NIMH-funded researchers
in the UPSOM. We clearly explain how the requested FIB-SEM will advance the research objectives of current
NIMH-funded projects and how this resource is invaluable for generating new NIMH grant applications. The
investigators in this proposal have decades of experience in traditional EM approaches, but these methods
cannot generate the quantity, or the quality, of data generated by FIB-SEM imaging. Therefore, there is a single
prime reason for this application: to provide critically needed, cutting-edge, high quality automated VEM imaging
to NIMH supported users within the UPSOM.

Public health relevance
8. Narrative Advanced imaging tools capable of generating high-resolution, high-precision, three-dimensional (3D) maps of cellular and synaptic architecture at the nanometer-level of resolution are required to answer fundamental questions regarding brain structure and function in mental health and disease. The advent of 3D volume electron microscopy (VEM) addresses this critical need by generating highly detailed connectomic maps of individually resolved synapses, and the sub-synaptic organelles within, across densely packed, large volumes of brain tissue. The focused ion beam-scanning electron microscope (FIB-SEM) requested in this application represents a fundamental tool in the practical application of VEM to brain tissue for a large number of NIMH-funded investigators at the University of Pittsburgh.